Administrative Core

SUMMARY FOR CORE A
Core A, the Administrative Core, will serve all four Projects, the Imaging Core (Core B), the Biomedical
Engineering Core (Core C), and Bioinformatics & Biostatistics Core (Core D), over all five years of the
Program. The goals of the Core include: 1) To provide administrative support and leadership to facilitate the
cross-disciplinary scientific and translational goals of our Program Project, and 2) To provide an environment
that enables critical self-evaluation designed to accelerate our scientific and translational aims.